Exploring the Interface between Substance Use Disorders and other Forms of Psychopathology using Phenotypic and Genomic Approaches

PROJECT SUMMARY/ABSTRACT
This K01 proposal integrates research and training to address gaps in our understanding of the associations
between substance use disorders (SUDs) and other forms of psychopathology. Extant research has
consistently demonstrated that SUDs share phenotypic and etiologic variance with other forms of
psychopathology, such as externalizing and internalizing. Despite this, most research into the classification and
etiology of SUDs treats them as isolated from each other and other forms of psychopathology. A clearer
understanding of the ways in which SUDs covary, both phenotypically and genetically, is essential to increase
specificity of SUD phenotypes, which can be used as targets in future research, and which can improve
classification and treatment in clinical settings. The overall goal of this award is to facilitate Dr. Poore’s
development as an independent scientist working at the intersection of psychiatric nosology,
statistical genetics, and translational science to uniquely equip her to address these research
questions. The proposed training integrates Dr. Poore’s background in clinical psychology and classification
of psychopathology with training in substance use, advanced statistical genetics methods, and translational
research skills. The following training objectives will be completed during the award period to accomplish these
goals: 1) training in the interface between SUDs and internalizing psychopathology; 2) training in
biological annotation of genetic variants and multi-ancestry statistical genetic methods; 3) integrating
basic and clinical research; and 4) gaining professional competencies essential for independence.The
research aims proposed in this K01 use multiple analytic approaches to understand the relationships between
substance use disorders and other forms of psychopathology and the extent to which better classification can
improve prediction of treatment response in a treatment seeking population. These analyses will rely on
several sources of data, including large, deeply phenotyped samples that include broad measures of
psychopathology and relevant outcomes, previously published genome-wide association studies of psychiatric
disorders, and data collected from individuals seeking treatment at the Rutgers University Behavioral Health
Center to accomplish the following aims: 1) Use advanced quantitative methods to model the phenotypic
overlap between SUDs and other forms of psychopathology; 2) Identify and characterize genetic
variants that influence SUDs and other forms of psychopathology; 3) Quantify the clinical utility of
phenotypic and genetic psychopathology clusters.

Public health relevance
PROJECT NARRATIVE The interface between substance use, externalizing, and internalizing disorders is complex and poorly characterized, which limits efforts to identify causes, correlates, and treatments for substance use disorders (SUDs). The training and research described in this proposal will integrate phenotypic classification of SUDs with statistical genetics and translational science to better characterize the phenotypic and genetic relationships among SUDs and other forms of psychopathology. This project has the potential to improve the specificity of phenotypes used in future studies, aid in gene discovery of SUDs, and improve the clinical utility of classification and gene-identification efforts for SUDs.